Capillary control of cerebral blood flow, and its disruption in small vessel disease

Summary
Neurons lack energy reserves and thus their survival depends on an uninterrupted, dynamically
regulated supply of blood-borne nutrients, which are delivered through a dense capillary network.
Precise control of the blood flow through the brain microcirculation is therefore essential for neuronal
health. However, the mechanisms through which blood is distributed within the capillary network
remains poorly understood. Furthering our understanding of this process is critical, as it is increasingly
appreciated that disruption of brain hemodynamics is one of the earliest pathological events in cerebral
small vessel diseases. Pericytes are mural cells that wrap around the endothelial cells forming the
capillaries. Our extensive preliminary data show for the first time that pericytes located on the first to
fourth order capillary branches constrict and relax in response to luminal pressure changes. This
observation implies that the resistance created by the capillary network is not constant and
homogeneous, but rather variable and dynamic, casting a new light on blood flow regulation.
Specifically, we have found that pressure-induced constriction in pericytes engages the autocrine
activation of the epidermal growth factor receptor (EGFR), subsequent inositol trisphosphate (IP3)
signaling, and transient receptor potential canonical 3 (TRPC3) activation. Using a well-established
genetic mouse model of CADASIL, a hereditary form of small vessel disease, we further propose that
pathogenic mechanisms depress the EGFR activation in pericytes, resulting in impaired capillary blood
flow autoregulation. To test these ideas, we engage a wide variety of novel, state-of-the-art experimental
approaches using intact animals, native tissue, and freshly isolated cells, complemented by
sophisticated computational modeling. Taking advantage of our newly developed pressurized arteriole-
capillary ex vivo preparation, Aim 1 will explore how EGFR activation by intraluminal pressure and
agonist-induced vasoconstriction contributes to γ1 phospholipase C (PLCγ1) activation and IP3-
dependent Ca2+ signals. Aim 2 will determine the mechanism linking EGFR and PLCγ1 activation to
TRPC3 channel opening to cause membrane depolarization and constriction. Finally, using
extracellular matrix disruptions characteristic of CADASIL as a framework, Aim 3 will provide the first
insights into the mechanisms by which pericyte contractility is regulated by EGFR and its upstream
regulators TIMP3, a matrix metalloproteinase inhibitor, and ADAM17, a metalloproteinase that
mediates shedding of the EGFR ligand, HB-EGF. The proposed work has the potential to provide a
paradigm-shifting view on how pericytes control capillary blood flow distribution, and as such, should
provide the foundation for understanding small vessel diseases of the brain.

Public health relevance
Narrative A deficit in cerebral blood flow hemodynamics is an early feature of cerebral small vessel disease—a leading cause of stroke and age-related cognitive decline—which suggests that cerebrovascular dysfunction has a key role in disease pathogenesis. Here we describe how some pericytes (cells that wrap around the capillaries) constrict in response to blood pressure to adjust blood flow through the dense capillary network, and demonstrate that this mechanism is disrupted in a mouse model of small vessel disease, leading to loss of blood flow control. Therefore, this work may identify novel targets on pericytes for therapies aimed at protecting or restoring blood flow in small vessel disease conditions.